Multiplexed neurochemical methods to understand adenosine neuromodulation

PROJECT SUMMARY
What is the role of adenosine as a rapid modulator of neurotransmission and how can we harness its power for
potential therapeutic use? To answer questions such as these, we need analytical tools that can measure
multiple neurochemicals simultaneously with high temporal and spatial resolution. Our lab pioneered fast-scan
cyclic voltammetry (FSCV) for adenosine, and discovered spontaneous, transient adenosine signaling that lasts
only a few seconds. However, the range and effects of rapid adenosine neuromodulation are not well understood.
Genetically-encoded sensors have recently been developed for neurotransmitter and calcium detection that offer
high sensitivity, selectivity, and spatial resolution. While they can monitor a wide variety of neurochemicals, and
not just electroactive molecules, there are still limited colors to detect different analytes. FSCV combined with
genetically-encoded sensors would be advantageous to detect the neuromodulator adenosine and measure its
downstream effects on dopamine and glutamate neurotransmission, as well as neuronal activity. The long-term
goal of my lab is to develop new tools for monitoring real-time neuromodulation in the brain. The goal of this
project is to develop multiplexed tools to understand neurochemical interactions and apply these tools to
understand adenosine modulation of glutamate, dopamine, and calcium. The central hypothesis is that rapid
adenosine release provides transient, but spatially localized, modulation of neurotransmitters in the brain. In the
first Aim, we will develop multichannel FSCV, with an array of four electrodes, to determine how far adenosine
diffuses in brain slices and the range of its neuromodulatory effects on dopamine release. In the second Aim,
we will combine FSCV with genetically-encoded fluorescent sensors to probe the spatial and temporal profile of
adenosine (measured with FSCV) modulation of dopamine (measured with GRABDA) or glutamate (measured
with iGluSnFR). In the third Aim, we will combine multichannel FSCV and in vivo fiber photometry measurements
of genetically-encoded sensors. We will demonstrate in vivo detection of adenosine, dopamine, and calcium
changes to probe adenosine neuromodulation of neurotransmission and neuronal activity simultaneously. This
research is significant because it develops tools that are broadly applicable for multiplexing neurotransmitter
and neuromodulator measurements, harnessing the combined strengths of FSCV and genetically-encoded
sensors. It is also significant because multiplexed tools will provide an unprecedented picture of the temporal
and spatial dynamics of adenosine neuromodulation. The biological impact is understanding the rapid and local
nature of adenosine neuromodulation, which is important for designing adenosine-based therapeutics for
diseases such as Parkinson’s, ischemia, or traumatic brain injury where adenosine could be neuroprotective.
The multiplexed tools could be applied to monitoring many other neurochemical interactions, in brain slices or in
vivo, and will advance the field of neurochemical monitoring beyond one neurochemical at a time sensing.

Public health relevance
PROJECT NARRATIVE Adenosine is an important neuromodulator that could provide neuroprotection during diseases, such as ischemia or traumatic brain injury, but little is known about the rapid mode of adenosine signaling to function during neuroprotection. Here, new technology is developed to allow measurements of multiple neuromodulators and neurotransmitters simultaneously. This technology is critical to understanding the rapid role adenosine plays in neuroprotection during stroke, and possibly developing therapies involving rapid adenosine release.